Identification and enrichment of signature regions of antimicrobial resistant pathogen genomes for wastewater disease surveillance

PROJECT SUMMARY/ABSTRACT
Antimicrobial resistance is recognized as a global public health threat that makes infections more difficult to treat
and increases the risk of other medical procedures. Global and local surveillance of antimicrobial resistance is
critical to understanding transmission of resistant pathogens, detecting the emergence of resistance
mechanisms, and mitigating the spread of resistant pathogens. Wastewater surveillance represents a powerful,
resource-efficient, and comprehensive approach for population-level surveillance of infectious diseases. It has
been widely applied to track COVID-19 and other respiratory virus levels in communities, as well as identify
circulating variants. However, wastewater surveillance of antimicrobial resistant pathogens has not been widely
implemented because of specific challenges that limit its actionability (i.e., the direct use of the surveillance data
to inform public health action). This is because antimicrobial resistance is ubiquitous in the environment and
even clinically-important antibiotic resistance genes (ARGs) are abundant and widespread in wastewater. Thus,
previous approaches that quantified ARGs generated information that was not specific to antimicrobial resistant
pathogens. This proposal focuses on the development of foundational computational tools and laboratory
methods necessary to identify and detect signature regions of antimicrobial resistant pathogens for wastewater
surveillance. Signature regions are defined as genomic regions that are conserved in a pathogen strain but not
found in neighboring strains or other genomes. We propose to develop a genomic language model approach to
identify signature regions of target antimicrobial resistant pathogens. This will be integrated with a fully
automated design pipeline for quantitative assay design. On the wet lab side, we will use microdroplet
encapsulation of wastewater microbes to do high-throughput enrichment and isolation of antimicrobial resistant
bacteria. This approach will enable sensitive and specific detection of antimicrobial resistant pathogens by
encapsulating individual cells and assaying them for signature regions using digital droplet PCR. The proposed
computational and laboratory tools will result in software and wet lab methodologies that can be used by public
health laboratories and wastewater surveillance programs for specific and sensitive antimicrobial resistance
monitoring. Software, assays, and protocols will be made publicly available and can also be applied for other
pathogen targets. Advancing the actionability of antimicrobial resistance wastewater monitoring has the potential
to enable the prediction of outbreaks, forecast hospitalizations, guide treatment decisions, understand
transmission, and evaluate mitigation strategies for antimicrobial resistant infections.

Public health relevance
PROJECT NARRATIVE Infections caused by antimicrobial resistant (AMR) pathogens are on the rise, leading to increased mortality rates, extended hospital stays, and higher healthcare costs. The proposed research will develop a genomic language computational approach and microfluidic laboratory methods to enable sensitive and specific wastewater monitoring of AMR pathogens. Project outcomes will advance the actionability of AMR wastewater surveillance, and ultimately inform strategies for mitigating the spread of AMR pathogens.